MOLECULAR BIOLOGY OF THYROID HORMONE RECEPTOR

The purpose of the study described in this report was to define the mechanism underlying quantitatively different thyroid hormone dependent transcriptional activation mediated by thyroid hormone receptors beta-1 and beta-2. We have shown that thyroid hormone receptor beta-2, which differs from beta-1 in the amino acid composition of the amino-terminal region, transactivates malic enzyme thyroid hormone response element (direct repeat + 4) and myelin basic protein thyroid hormone response element (inverted palindrome) poorly, when compared with the transactivation mediated by the beta-1 or alpha-1 receptor. This is not due to different levels of beta-2 and beta-1 expression or the inability of beta-2 to bind to thyroid hormone response element. However, thyroid hormone receptor beta-2 cannot interact with TFIIB as efficiently as the thyroid hormone receptor beta-1. Thus, we concluded that the amino terminal regions of thyroid hormone receptor beta-2 does not affect the receptor binding to thyroid hormone response element; however, it is required in communicating information via TFIIB to the basal transcription machinery, although interactions with other basal transcriptional factors cannot be excluded.